Mechanistic registry to study whether infection with Corona Virus Disease 2019 (COVID-19) accelerates atherosclerotic plaque progression

Project Summary / Abstract
The primary objective of the corona virus disease 2019 (COVID-19) (COVID-CT) registry is to determine if
infection with the severe acute respiratory syndrome coronavirus-2 (SARS-CoV-2), the virus which causes
COVID-19, results in marked progression of coronary atherosclerotic plaque in patients with previously defined
anatomic coronary artery disease (CAD). COVID-19 induces a pro-inflammatory cytokine release and pro-
thrombotic processes that we hypothesize will accelerate atherosclerotic plaque progression. Coronary
computed tomographic angiography (CCTA) is a robust noninvasive method uniquely capable of measuring
angiographic stenosis and quantifying and characterizing atherosclerotic plaque. Our group has extensive
experience in large multicenter trials and registries using CCTA to identify key atherosclerotic plaque features
associated with progression and major CAD events. Moreover, we propose use of a novel CT marker of coronary
artery inflammation - the perivascular fat attenuation index (FAI) – a marker highly predictive of acute CAD events
and to assess serial changes in coronary inflammation.
COVID-19 is rapidly becoming a leading cause of death with substantial evidence that pre-existing CAD
increases risk of serious illness and mortality from COVID-19. By enrolling patients with high risk, atherosclerotic
plaque, findings from the COVID-CT registry will inform this link between the inflammatory response sustained
during COVID-19 to accelerated atherosclerotic plaque progression. If our hypotheses are confirmed, then
clinicians and patients will have clear information that viral infections, such as SARS-CoV-2, alter the
inflammatory milieu and accelerate progression of atherosclerosis. Importantly, a connection between COVID-
19 and CAD will broadly impact preventive risk assessment for the ~7 million patients infected with SARS-CoV-
2 and millions more yet to be tested in the United States.
To date, evidence is lacking as to whether the COVID-19 results in marked atherosclerotic plaque progression
among racially and ethnically diverse patients with CCTA-defined CAD who reside across a socioeconomically-
diverse, urban setting. The present proposal constitutes a comprehensive approach assessing the clinical
importance of atherosclerotic plaque progression following COVID-19. Currently, the implications of epicardial
coronary injury following SARS-CoV-2 infection is unknown. Yet, the inflammatory pathway of atherosclerotic
plaque progression is well studied and, as such, our hypotheses are supported by this knowledge base. The
proposed COVID-19 registry is poised to provide an improved mechanistic understanding of the role of viral
infection on alterations in atherosclerotic plaque.

Public health relevance
The COVID-CT Registry is a study to determine if coronary artery disease patients with a history of COVID-19 infection in New York City have more inflammation, resulting in faster development of plaque in their coronary arteries. CAT scans of the heart’s arteries will be used to measure inflammation, stenosis (narrowing of the blood vessels), and plaque (cholesterol deposits) which are all associated with major cardiac events.